Project 3: Development of Novel Antibody Drug Conjugates for the Treatment of Osteosarcoma

PROJECT 3: ABSTRACT
Strategies to reduce the morbidity and mortality from pediatric osteosarcoma (OS) are critically needed. 30 to
40% of OS patients recur after receiving highly toxic chemotherapy, In the past three decades, there have been
no new therapies successfully developed for this cancer with. Antibody drug conjugates (ADCs), designed to
specifically bring cancer drugs, known as payloads, to tumor cells while leaving normal cells unharmed,
represent a promising strategy. Several ADCs have been FDA approved for a variety of cancers, but none for
osteosarcoma. Thus, Project 3 will focus on the development and clinical translation of ADCs specific to surface
proteins abundantly present in OS coupled to relevant payloads. Preliminary data provides compelling evidence
that OS expresses readily available cell surface proteins which can serve as potential targets for therapies and
could serve as epitopes for endogenous immune responses and immunotherapies. To clinically translate newly
developed immunotherapies and targeted therapies more efficiently, determining which OS patients will or which
patients will not respond to therapy is key for appropriate patient selection. Selecting which patients are likely to
respond could be guided by the identification and validation of blood biomarkers. Recent biomarker studies have
shown that exosomes, which are representative of and shed from tumor cells into the blood circulation, can
provide useful information on tumor evolution, metastasis, and cancer recurrence and/or relapse risk. In the first
aim of this work, studies of ADCs targeting cell adhesion molecule 1 (CADM1), a protein highly expressed in
OS, will be performed in OS patient derived xenograft (PDX) models for payload optimization, understanding of
emerging drug resistance, and as studies to enable IND filing. In the second aim we will develop bispecific
antibodies (Bs)ADCs that target two different OS surface proteins. While the terminology bispecific usually refers
to antibodies which lead to T cell engagement, in this case our goal is to combine two different antigen targets
on one antibody to enhance affinity and specificity. Our intent is to focus on combining CADM1 and T-cell
checkpoint ligand B7-homologue (B7H3), which is also known to be a highly relevant target in OS. These
bispecific antibodies will be tested for efficacy as ADCs. In the third aim a phase 1/2 trial of an already developed
ADC will be conducted in patients with osteosarcoma. In addition to evaluating the safety and preliminary efficacy
of an B7H3-targeting ADC, this aim will also allow the development of an OS liquid biopsy approach using
circulating exosomes to identify signatures predictive of response to treatments. Biospecimens obtained in this,
trial as well as other acquired OS samples, will permit additional profiling of the cell surfaceome (both proteins
and their post-translational modifications) to identify novel, preliminary OS surfaceome targets as well as explore
drug resistance. It is expected that this work will significantly improve the lives of OS patients through the
identification of effective and potentially less toxic therapies.

Public health relevance
PROJECT 3: NARRATIVE Patients with osteosarcoma, the most common primary malignant bone sarcoma in adolescents and young adults, have had no change in survival over the past several decades because of the paucity of new effective drugs. In this proposal, novel antibody drug conjugates (ADC’s), a promising new class of agents that direct drugs directly to cancer cells using target specific antibodies, will be developed for osteosarcoma by focusing on an osteosarcoma specific target or multiple targets that will make the treatment more effective with less side effects. As part of this project, a clinical trial will be conducted in patients with recurrent osteosarcoma to gauge the safety and efficacy of a novel ADC, while at the same time collecting tumor and blood samples, when possible, to understand why the treatments were effective or not effective in each individual.